A Phase 2 Trial of Axelopran Plus Pembrolizumab for the First-Line Treatment of Recurrent/Metastatic HNSCC That Is PD-L1 Positive (PD-L1CPS >1)

The proposed project will test if the addition of axelopran, a peripherally-restricted opioid antagonist, to standard of care
pembrolizumab will increase objective response rate vs. historic controls in recurrent or metastatic head & neck
squamous cell carcinoma (R/M HNSCC) with a CPS≥1, who are also taking opioid analgesics to control cancer-related
pain. This is the first step of a development program that will seek approval for axelopran as an adjunctive therapy to
immune checkpoint inhibitors in R/M HNSCC, and ultimately other solid tumors. Pain is a common symptom of advanced
cancer, and is particularly prevalent in R/M HNSCC due to the sensitive nature of the tissues affected. Opioid analgesia is
a vital cornerstone of adequate pain control, an imperative for patient quality of life. However, growing evidence
demonstrates that opioid analgesia interferes with checkpoint inhibitor efficacy, and this has recently also been shown in
R/M HNSCC by our collaborators at the University of Pittsburgh. A peripherally-restricted antagonist is an appealing
strategy to address this problem, because it can block the peripheral actions of the opioid, which have been shown in a
mouse model to impair checkpoint inhibitor efficacy, without impairing imperative patient pain control. The proposed
research plan will test the efficacy of axelopran in improving objective response rate per RECIST 1.1 by comparing against
historic controls from University of Pittsburgh Medical Center who received opioid analgesia concomitantly to immune
checkpoint inhibitors for R/M HNSCC. It plans to enroll 18 patients in two stages: 5 patients for a futility analysis (where 1
response would show non-futility) and 13 further patients (where 7 responses out of 18 total patients would show
significant improvement over a historical comparator of 11.4% ORR). The proposed clinical study would also determine
safety and tolerability of adding axelopran to pembrolizumab in this population, which is a new study population and
therapeutic combination for axelopran. Axelopran has previously been studied in >500 non-cancer patients for the
indication of opioid-induced constipation, providing a known therapeutic dose that saturates peripheral receptors, and a
clear expectation of potential adverse events that inform the safety and tolerability analysis. If the study is successful, we
anticipate further dialog with the FDA, with the goal of initiating, with registrational intent, a larger randomized
controlled trial vs. placebo in the same target population.

Public health relevance
Clinical evidence now shows that opioids used to control cancer pain significantly reduce the survival of cancer patients treated with current standard of care immunotherapy agents. This SBIR Phase II project will test axelopran, an opioid antagonist, that in pre-clinical models has been shown to completely reverse the opioid blockade of immunotherapy agents while leaving pain control intact. If successful, the results will initiate further study for an FDA approval process that will lead to the product’s ultimate use in all solid tumor cancer patients who receive opioids and immunotherapy agents, resulting in increased overall survival rates for a large proportion of the cancer population.